Cellular-molecular regulation of isoform-dependent tau dysfunction in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Hyperphosphorylation to the microtubule (MT) associated protein Tau is the primary driving force of Tau
aggregation, a pathological hallmark of Alzheimer’s disease. Tau binds to and stabilizes MTs, especially in
neuronal axons. Phosphorylation causes Tau to dissociate from MTs, thus destabilizing them while also
increasing the vulnerability of Tau to further phosphorylation and toxic aggregation. Yet, clinical trials aimed at
either stabilizing MTs or degrading phospho-Tau (pTau) have yet to succeed. A major caveat of these trials is
that they did not stabilize the interactions of specific Tau species to MTs, which is a feasible strategy to stabilizing
Tau function and preventing its toxic aggregation. It has been challenging to achieve this clinical goal because
there are critical gaps in the Alzheimer’s disease field in distinguishing pathological from functional pTau species,
and mapping dysregulation of the pathways that drive Tau toward its hyperphosphorylated state.
Most Tau research to date has focused exclusively on the longest Tau isoform even though it is the least
abundant isoform in the brain. However, there are a total of 6 Tau isoforms in the brain, expressed at varying
protein levels. I have made several discoveries connecting phosphorylation of Tau to its function and dysfunction
in an isoform-dependent manner. I found that i) Tau isoforms have different phosphorylation levels in human
neurons, ii) pTau species that are associated with Alzheimer’s disease are also abundant and soluble in normal
developing brains, iii) phosphorylation regulates Tau-MT interactions and aggregation levels in an isoform-
dependent manner. These findings support my central hypothesis that phosphorylation impacts Tau-MT
interactions in an isoform-dependent manner (AIM 1), modulated by isoform-specific regulation of Tau-MT
interactions (AIM 2).
While the study of Tau hyperphosphorylation is a rich field, many studies have been limited by Tau
overexpression systems and/or exclusive focus on pathology. Furthermore, high-throughput tools to test for
regulators of Tau-MT interactions were not available until recently. I will address these concerns by using new
technologies to contrast Tau function and pathology. I will receive training to apply CRISPR prime editing, a new
and highly efficient gene editing technique with reduced off-target effects, to endogenously edit phosphorylation
sites of interest to Tau to test for isoform-specific effects on its binding to MTs in neurons (AIM 1). Second, I will
apply a powerful new technology, pooled optical CRISPR screening, to identify trans-regulators that increase
dissociation of Tau from MTs. Optical screening allows for genotype-phenotype matching of virtually any
phenotype that can be imaged under a microscope. This aim will uncover both known and novel genetic risk
factors for Alzheimer’s disease, thus opening several avenues for my future studies beyond this proposal.

Public health relevance
PROJECT NARRATIVE Hyperphosphorylation of microtubule (MT) associated protein Tau is tightly correlated with Alzheimer’s disease progression; however, studies of isoform-specific effects of Tau function and dysfunction are largely unexplored. I discovered that phosphorylation differentially regulates adult and fetal Tau isoforms: Tau isoforms have distinct phosphorylation patterns in neurons, and specific phosphorylation sites impact Tau-MT interactions in an isoform-dependent manner. I uniquely propose to use high-throughput pooled optical CRISPR screening and CRISPR prime editing to contrast the effects of Tau phosphorylation (AIM 1) and regulators of Tau-MT interactions (AIM 2) on its function and dysfunction between fetal and adult Tau isoforms, thus providing insight into both loss-of-function and toxic gain-of-function mechanisms in Alzheimer’s disease and other related dementias.